Bacterial translocation to mesenteric adipose tissue drives pathogenic stromal-B cell interactions leading to inflammatory IgG

Project Summary
Anti-microbial antibodies are predictive of Crohn’s disease (CD) diagnosis and are present in patients’ serum up
to 5 years before diagnosis, and their accumulation is associated with complications, often requiring bowel
resection surgery. In patients with CD, more bacteria translocate to the mesenteric adipose tissue (MAT)
compared to controls and a subset of bacteria are exclusive to CD MAT. This coincides with the expansion of
the MAT and its wrapping around the intestine, or “creeping fat”, a hallmark of inflamed CD-affected tissue, which
also correlates with complications. The etiology of anti-microbial antibodies and creeping fat are unknown.
Although B cells and stromal cells co-localize within fat-associated lymphoid clusters in creeping fat, and B and
plasma cell signatures are among the most highly upregulated genes in creeping fat compared to healthy MAT,
B cell function in this tissue is unknown. We hypothesize that the translocation of microbes to MAT prompts
stromal cells in fat-associated lymphoid clusters to recruit B cells, which differentiate into protective IgM-secreting
plasma cells, inhibiting systemic dissemination of bacterial antigens. Sustained CD-specific bacterial
translocation to the MAT leads to chronic inflammation activating stromal cells to secrete cytokines driving IgG
class-switch and differentiation to inflammatory anti-microbial IgG-secreting plasma cells. Adipocyte-derived
leptin is elevated in MAT of CD patients and drives inflammation in mouse colitis models. As leptin activates B
cells, we posit leptin further drives preferential class-switch to IgG. We will address this hypothesis in germfree
mice reconstituted with cultured collections of bacteria isolated from CD or healthy donors, as well as in human
MAT associated or not with inflamed intestine from patients with CD undergoing bowel resection surgery at
Mount Sinai. In these models, we will evaluate which bacteria translocate to the MAT, how they activate stromal
cells by deep characterization at the transcriptional and protein level and how they drive leptin production by
adipocytes in biopsy cultures (Aim 1). Next, we will investigate direct and indirect effects of CD microbiota on
MAT B cells and their shift from protective IgM to inflammatory IgG. To do so we will characterize CD microbiota-
driven changes in B cell activation, proliferation, class-switching and differentiation to plasma cells. We will also
determine the IgG-inducing properties of MAT and stromal cells exposed in vivo to CD or healthy donor
microbiota. Finally, we will investigate how CD microbiota perturbs stromal-B cell cross-talk within fat-associated
lymphoid clusters (Aim 2). By showing that MAT is able to mount microbiota-specific B cell responses, this
proposal will expand the study of mucosal immunology to mucosa-associated adipose tissues. Since creeping
fat and anti-microbial IgG correlate with complications in CD, these studies have the potential to uncover
mechanisms underlying CD pathology and identify needed therapeutic targets.

Public health relevance
Project Narrative Crohn’s disease is an inflammatory bowel disease that has no cure and often leads to disease complications requiring bowel resection surgery. The origin of two phenomena correlating with development of Crohn’s disease complications, mesenteric adipose tissue wrapping around inflamed intestine, or “creeping fat”, and circulating anti-microbial antibodies, are poorly understood. By studying how Crohn’s disease-specific bacterial translocation to mesenteric adipose tissue leads to activation of stromal cells and adipocytes, in turn driving inflammatory B cell responses, this proposal has the potential to uncover mechanisms underlying CD pathology, identify novel therapeutic targets, and expand the study of mucosal immunology to mucosa-associated adipose tissues.